Relationship of exercise frequency, intensity, and fitness to improved cognition and biomarkers in Gerofit participants

Gerofit is a Veteran Health Administration health promotion program which has demonstrated significant gains
in physical function, general well-being and other health outcomes. However, overall cognitive benefits of the
program have not yet been assessed. The goal of this study is to determine the relationship between physical
function improvements from participation in the Gerofit exercise program and cognition in older Veterans.
Specifically, this study will be testing 1) whether participation in the long-standing, widely available VA Gerofit
program improves cognitive measures of memory and executive functioning after three months and one year in
older Veterans compared to controls; and 2) the predictive power of peripheral blood and/or skeletal muscle
biomarkers for the physical and cognitive effects after three months and one year of Gerofit participation in
older Veterans compared to controls. By accomplishing these goals, the results can provide more information
about the role of exercise in cognitive improvements in older adults, specifically within the VA Gerofit exercise
program, and the use of predictive biomarkers to determine which Veterans will obtain the most benefit
cognitively and physically.

Public health relevance
Over 50% of the Veterans enrolled for VA health care are over the age of 65. Dementia prevalence increases with age, and with the increase in the population of people ages 65 and older, the total number of people with dementia is also increasing. Older Veterans often have comorbid PTSD, major depression and traumatic brain injury so that they are at 2 to 5 times the risk for cognitive impairment and dementia compared to the general population. There is evidence that exercise interventions in sedentary older adults could improve both physical and cognitive function. However, there have been very few studies on the effects of exercise on cognition in older Veterans and do not reflect the broader ethnic and health-status diversity of Veterans. Thus, improved knowledge of the role of exercise on cognition as well as the predictive power of biomarkers could have a major beneficial impact on Veterans’ functional independence and quality of life.